Chemical Probes and Drug Discovery

CORE B – PROJECT SUMMARY
The Chemical Probes and Drug Discovery (Core B) will provide state-of-the-art assay development, screening,
and synthetic/medicinal chemistry expertise to support all three Projects. In Project 1, Core B will develop new
EBNA1 Probes and DNA-Tacs targeting EBNA1 degradation. Degraders of EBNA1 are predicted to be more
efficacious. Novel approaches for degraders will leverage shRNA PLOD1 silencing showing EBNA1 degradation
and the use of novel EBNA1 targeted PLOD1 inhibition. We will use small DNA oligos as targeting ligands
conjugated to E3 ligase recruiting molecules as chemical tool compounds for degradation of EBNA1. In Project
2, we will develop selective PARP1 degraders and compare these to known PARP inhibitors to compare the
effect of degradation of PARP1 protein compared to inhibition of PARP1 enzymatic activity. We have shown that
PARP inhibitors and importantly PARP PROTACs synergize with ATR inhibition, ATM inhibition, and decitabine.
The observation that PARP1 selective PROTACs kill SNU719 cells equally or with greater potency as Olaparib
suggests trapping may not be required for bioactivity. We have developed prototype PARP1 inhibitors using the
clinically relevant PARP inhibitor Olaparib conjugated to E3 ligase recruiting ligands to recruit cereblon (CRBN)
or Mdm2. We found that our prototype compounds selectively degrade PARP1 and have observed that
degraders utilizing the Mdm2 recruiting ligand are effective in killing SNU719 EBV gastric cancer cells. We utilize
an innovative plate based In-Cell Western assay to optimize the activity of the PROTACs to increase the assay
through-put and accuracy, and to prioritize compounds for Western blot confirmation. In Project 3, we will
develop novel inhibitors and degraders for UHRF1, an important protein that plays a key role in maintaining DNA
methylation in mammalian cells. Core B has developed an HTRF assay for measuring UHRF1 binding to specific
trimethyl-lysine ligand to further enable the development of UHRF1 degraders and inhibitors that block its
mechanism in CIMP. Preliminary screening results have identified potent sub-micromolar UHRF1 ligands,
including bi-functional molecules being evaluated as novel UHRF1 degraders.
Core B will also provide assay development and screening for all the Projects. For example, synergy
screening in the EBV positive SNU719 gastric cancer cell line typically using the NCI library of known pan-cancer
drugs and epigenetic library of known clinical drugs. The specific aims for Core B are (1) to provide state-of-the-
art Synthetic chemistry/ Medicinal chemistry capabilities to design and synthesize chemical probes for all the
projects, and (2) to develop suitable biochemical and cell-based assays to support probe optimization efforts and
to provide synergy screens to enhance the activity of our current probes.

Public health relevance
CORE B – PROJECT NARRATIVE The Chemical Probes and Drug Discovery (Core B) will support all three Projects and work coordinately with Cores A and C to develop new therapeutic strategies to treat EBV epithelial cancers. Core B will provide synthetic/medicinal chemistry expertise and high-throughput drug combination screening for all the Projects. Core B will develop new chemical probes and small molecule inhibitors of viral and host epigenetic modulators to investigate and develop new therapeutic strategies to treat latent infection of EBV focusing on epithelial cancers.